Center for Cell-based Therapy - Cures

The mission of the Center for Cell-based Therapy is to facilitate the discovery and development of cellular immunotherapies for patients with cancer. Two important objectives of this work are: (1) developing approaches to successfully target solid tumors with cell-based immunotherapy, and (2) facilitating collaborative cell-based therapy projects with strong clinical potential. Four areas currently in development for this project are: (1) developing CAR-T Cells targeting GPC2 as a treatment for Neuroblastoma in collaboration with Mitchell Ho, Rosandra Kaplan, and Carol Thiele; (2) creating CAR-T Cells targeting mesothelin as a therapy for mesothelioma and lung adenocarcinoma in collaboration with Mitchel Ho and Ira Pastan; (3) developing CAR-T cells to deliver genes of interest into the tumor micro-environment in collaboration with Mitchell Ho; and (4) identification of key genes driving immune suppression and tumor killing in myeloid cells in collaboration with Rosandra Kaplan. This could potentially facilitate the improvement of cell-based therapy strategies.